Development of an innovative tool to improve mTBI patient-provider communication of visual impairment symptoms

PROJECT SUMMARY
Visual disturbances as a result of a traumatic brain injury (TBI) are an overlooked symptom. The
screening identification and referral process need to be improved. Invisible injuries are
challenging to describe, and imaginations are left to fill in details. Most concussion forms and
questionnaires (such as the Rivermeade post-concussion symptom questionnaire) allow a
patient to indicate only that vision is double, blurry or light sensitive, resulting in many
overlooked visual symptoms from TBIs. Additional symptoms can include visual snow, pixilation,
photopsias, etc. Because a word-based language does not fully capture visual symptoms,
categories (such as "double") can be overlooked by patients, especially when the patient does
not identify with the clinical word used by providers. Words such as smeared, blurred, 3D vision
without the glasses on, layered, shadowed (all words from a patient perspective) may not mean
the same thing to a provider and patient. These words could all describe “double vision” or
something else potentially. Visual problems associated with TBI are not captured by the current
standard of care for TBI patients, including using these forms which can allow symptoms that
are vaguer to slip between the cracks because they are more challenging to describe. What
Lies Beneath Concussion is attempting to address this gap by developing a product that will
bridge the communication gap between patients and providers by using custom created imagery
to reflect visual symptoms from the patient perspective to improve the standard of word-based
forms, questionnaires, and oral conversations. Our tool will improve the symptom identification
process, provider-patient communication, provide reports to clinicians, and provide triage
information to non-eye care providers. We are revolutionizing how visual impairments are
screened by optometrists and ophthalmologists and non-eye care providers by
pioneering this visual tool to assess visual impairments. What Lies Beneath intends to
establish core content, receive feedback from potential users on content alignment, and conduct
a mixed-methods evaluation of image relevance to individual mTBI patients with visual
disturbances. Completing these goals will position us for follow on studies in Phase II which will
enable us to further develop our product.

Public health relevance
PROJECT NARRATIVE An estimated 69 million people worldwide experience a traumatic brain injury (TBI) every year. While visual disturbances are the most commonly reported symptoms, vision care and vision testing is lacking at the initial clinical evaluation. What Lies Beneath is pioneering a groundbreaking visual tool for assessing visual impairments associated with brain injuries and neurological disorders to bridge this gap.